Convergence of multiple exposures during pregnancy: Effect of wildfires and maternal stressors on birth outcomes among Alaskan women

PROJECT SUMMARY (ABSTRACT)
The research objective of this K01 is to understand how wildfire smoke (WFS) exposure and other maternal
stressors converge and contribute to preterm birth differentially across socio-demographic groups. Prematurity
is a major determinant of newborn death and disability. There are substantial disparities in the U.S. where the
rate of preterm births among American Indian/Alaska Native women is 26% higher than the rate among all U.S.
mothers. The research will consist of three Specific Aims. (Aim 1): Evaluate the association between exposure
of pregnant women in Alaska to WFS and preterm birth. We hypothesize that maternal WFS exposure is
associated with adverse birth outcomes, particularly when exposed at critical developmental windows during
gestation. We will develop a historical, spatially explicit WFS layer using the NOAA HYSPLIT model. We will
combine model output with Alaskan birth records from 2000-2020 (n=220,000) to estimate associations between
WFS exposure and birth outcomes, controlling for maternal smoking, age, parity, and pre-pregnancy co-
morbidities. (Aim 2): Assess effect modification of the relationship between WFS exposure and adverse birth
outcomes by maternal characteristics, access to healthcare, and geographic remoteness. We will utilize
information from birth records to conduct stratified analyses. We hypothesize that maternal socio-demographic
characteristics modify the relation between WFS exposure and birth outcomes. (Aim 3): Test the combined effect
of stressful life events during pregnancy and WFS exposure on preterm birth. Using a subset of our sample
included in the Pregnancy Risk Assessment Monitoring System (PRAMS), we will include measures of stress by
domain (e.g. financial, relationship) and number of stressful life events as interaction variables with WFS
exposure. The candidate is a tenure-track Assistant Professor of Environmental Health at the University of
Alaska-Anchorage with training in epidemiology, biostatistics, ecology methods, and GIS. Her short-term career
goals are to expand her research on wildfire epidemiology, and to develop a research program to understand
how health disparities in Alaska contribute to the health impacts of climate change. Her long-term career goal is
to lead an applied research group that conducts rigorous, community-responsive research. This career award
will support her training in health disparities and mixed methods research, qualitative analysis, advanced
statistical methods, and integration of health equity into adaptation planning. Her department/mentor team have
expertise in environmental epidemiology, biostatistics, air quality modeling, and translational research, and her
campus offers many opportunities to support junior faculty. These experiences and resources will support the
work proposed here, as well as future interdisciplinary research on environmental justice issues. This proposal
supports the NIMHD mission to improve minority health and reduce health disparities by strengthening rigorous
quantitative and qualitative methods to enable analysis on small populations and developing methodologies for
incorporating and using geographic identifiers in health disparities research to promote place-based research.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Globally, complications of preterm birth are the single largest direct cause of neonatal deaths, accounting for 35% of over 3 million annual deaths. While the specific causes are poorly understood, many have identified disparities in preterm birth by maternal socio-demographic characteristics such as race, age, and educational attainment, and the independent and joint effects of social and environmental factors over the maternal life course, as contributing to the risk of adverse birth outcomes. A better understanding of the interaction between wildfire smoke exposure and social risk factors as they relate to birth outcomes and can support interventions to promote healthy fetal development in an era of increasing wildfires.